Role of pH-mediated metabolic reprogramming in β cell failure in Type 2 Diabetes Mellitus

Type 2 diabetes mellitus (T2DM) manifests through the development of fasting and postprandial hyperglycemia the etiology of which can be distilled to failure of pancreatic β cells to maintain appropriate glucose-stimulated insulin secretion (i.e. β cell function) to compensate for the decline in insulin action (i.e. insulin resistance). Thus preservation of β cell function has been identified as a critical barrier for the development of successful preventative and treatment strategies to combat the rise in T2DM prevalence. Studies suggest that β cell dysfunction in T2DM is associated with metabolic reprogramming/shift toward increased non-oxidative glucose metabolism and reduced mitochondrial function similar to an adaptive features observed in cancer cells. Accordingly, cancer cells facilitate increased glycolytic flux and subsequent rise in metabolic acid production by upregulating expression of ion pumps/transporters that enhance cellular buffering capacity and promote cellular alkalinization (increased pHi), such as SLC4 family of bicarbonate transporters. Although, previous studies have confirmed importance of pHi for proper β cell functionality, it is unknown whether intracellular alkalinization or increased pHi buffering contributes to β cell functional decline in T2DM. Thus, the key objective of the current proposal is to test the hypothesis that aberrant induction of a novel T2DM gene SLC4A4 and its protein product (electrogenic Na+-coupled HCO3- cotransporter, NBCe1) in β cells contributes to β cell functional decline in T2DM. To address this hypothesis, Specific Aim 1 will 1) perform detailed examination of SLC4A4/NBCe1 expression using our unique collection of autopsy-derived human pancreas from patients with obesity, pre-diabetes and T2DM and 2) elucidate molecular mechanisms mediating aberrant
β cell induction of SLC4A4/NBCe1 in response to diabetogenic stressors. Specific Aim 2 will utilize novel genetic gain-of-function tools to test the hypothesis that intracellular alkalinization mediated by increased β cell expression of SLC4A4/NBCe1 leads to β cell functional failure through impairment of mitochondrial metabolism and function. Finally, Specific aim 3 will utilize novel genetic loss-of-function animal models and T2DM human islets to test therapeutic potential of inhibiting SLC4A4/NBCe1 expression/activity in β cells as means to attenuate β cell failure and improve overall glucose metabolism under diabetogenic conditions. The current project will uncover novel molecular/physiological mechanisms underlying induction of β cell dysfunction and
test a potentially novel therapeutic strategy to attenuate of β cell failure in T2DM.

Public health relevance
Development of Type 2 diabetes leads to severe health complications that afflict both the quality and the length of life and burden health care systems with direct global spending estimated at nearly $500 billion per year. Type 2 diabetes results due to impaired function of pancreatic β cells, which function to produce and secrete insulin to maintain normal glucose levels. The goal of this proposal is to investigate novel molecular and physiological mechanisms responsible for the regulation of pancreatic β cell function as people progress to develop Type 2 diabetes. In addition, proposed studies will also test a new therapeutic strategy to preserve the functionality of β cells once they are exposed to conditions associated with obesity and diabetes.